Effects of the NR2E1 mutation on cellular and molecular determinants of neurogenesis

Abstract
The ability of neural stem cells to give rise to mature neurons, a process known as neurogenesis, is crucial for
the developing and adult mammalian brain. Dysregulation of this process has been associated with several
pathologies including cognitive impairment and depression. Thus, there has been an increased interest to
study neurogenesis as a potential therapeutic target to counteract these pathologies. Nuclear receptor
subfamily 2, group E, member 1 (NR2E1) has been considered a master regulator of neurogenesis. Loss of
Nr2e1 in the mouse model significantly impairs neural stem and progenitor cell proliferation and neurogenesis,
ultimately leading to hippocampal hypoplasia and a decline in learning and memory. In contrast,
overexpression of Nr2e1 improves learning and memory and diminishes anxiety behaviors. Despite the
importance of Nr2e1 for neural stem cell biology and neurogenesis, we still do not know whether NR2E1 is
important in humans, whether NR2E1 genetic variants exist, and if so, whether they cause any pathology. To
answer these questions, we performed a thorough screening of multiple undiagnosed patient databases and
identified several patients with different NR2E1 de novo single nucleotide variants leading to missense
mutations in its coding sequence. All patients present with mild-to-moderate intellectual disability and various
behavioral issues, from impulsive to aggressive behaviors. To establish causality, in this proposal we focus on
one identified mutation, I385T, located at the C-terminal of the NR2E1 ligand-binding domain. We hypothesize
that NR2E1 I385T mutation dysregulates neurogenesis by impairing NR2E1 function, leading to poor
learning and memory. To understand the molecular consequences of this mutation, we will first assess how
I385T affects NR2E1's ability to interact with its ligand and co-regulators using biophysical and in vitro assays
(Aim 1). Second, we will determine the cellular and behavioral effects of I385T mutation by studying it in two
complementary models: a CRISPR-Cas9 engineered mouse model (Aim 2) and a patient-derived human brain
organoid model (Aim 3). Mouse model studies will inform whether neurogenesis is impaired throughout life
from the embryonic stage to adulthood, resulting in behavioral anomalies. Patient-derived brain organoid
studies will inform how I385T mutation specifically affects early human neurogenesis. This is very important for
future attempts to develop small molecules to rescue NR2E1 activity in patients with this mutation. Overall, the
findings of this proposal will further our understanding of the causative relationship between NR2E1 mutation
and human pathology and pave the way for a personalized therapeutic approach for the affected individuals.

Public health relevance
Project Narrative The decline of neurogenesis has been associated with many neurological disorders. Considering the critical role NR2E1, a nuclear receptor, plays in regulating neurogenesis, it is likely that certain NR2E1 missense mutations might cause neurogenesis-associated pathology by impairing NR2E1 function and/or activity. Our project will investigate the molecular, cellular, and behavioral consequences of one patient-specific NR2E1 mutation to gain insight into the importance of NR2E1 for human neurogenesis.